Understanding the role of ubiquitination-like processes in bacterial antiviral immunity

PROJECT SUMMARY/ABSTRACT
Eukaryotic ubiquitination involves the conjugation of one protein to another through the sequential activity of
three enzymes, E1, E2, and E3. These enzymes catalyze the transfer of ubiquitin or ubiquitin-like proteins onto
target protein substrates. Ubiquitination contributes to the regulation of a wide variety of eukaryotic cellular
processes, including protein degradation, gene transcription, DNA repair, and cell cycle control. Another
important role for ubiquitin or ubiquitin-like protein conjugation is in the human innate antiviral immune response.
During infection, the innate immune system serves as the first line of defense against viral threats. By recognizing
the foreign, or “non-self”, components of the virus, the immune system activates various pathways to prevent
widespread infection. Two examples of antiviral innate immune pathways that are known to be regulated by
canonical ubiquitin or ubiquitin-like protein conjugation are cGAS-STING and ISG15, but many of the mechanistic
details of these pathways have yet to be uncovered. Recently, operons in bacteria have been discovered that
encode E1 and/or E2 ubiquitin transferase domains, and, in some instances, canonical ubiquitin-like proteins.
These operons have been defined as bacterial innate immune systems that function through protein conjugation
mechanisms and are evolutionarily related to the human cGAS-STING and ISG15 immune pathways. Here, I
have proposed a multidisciplinary strategy to understand the molecular mechanisms of protein conjugation used
by bacterial defense systems. In one of these systems, an E1-E2 ubiquitin transferase enzyme, Cap2,
conjugates a non-ubiquitin-like protein, a signaling enzyme called bacterial cGAS, onto an unknown target
molecule to protect bacteria from phage infection. I will use mass spectrometry-based proteomics, mechanistic
biochemistry, and phage infection assays to explore how phage defense is achieved through conjugation of a
non-ubiquitin-like protein (cGAS) in this system. I will also explore the mechanisms of the bacterial ISG15-like
(Bil) and two other ubiquitin protein-containing defense systems using mechanistic biochemistry and mass
spectrometry. Specifically, I will determine how the conjugation of canonical ubiquitin-like proteins confers
defense against phage infection. Deciphering the details of ubiquitination-like processes in bacterial innate
immunity will inform our understanding of the underlying mechanisms of conserved human innate immunity
pathways, including cGAS-STING and ISG15. Gaining new insights into these mechanisms could pave the way
for developing novel therapeutics that modulate the human immune response during viral infection.

Public health relevance
PROJECT NARRATIVE Human innate immune pathways are vital for defense against viruses. Mechanistic details regarding the role of ubiquitin-like conjugation in these pathways (e.g. cGAS-STING and ISG15) are not fully understood, but we can glean insights into these missing details through an understanding of bacterial antiphage systems that use similar ubiquitination-like pathways to confer defense. Here, I will explore the mechanisms of ubiquitin-like conjugation in bacterial phage defense, with the goal of improving our understanding of the evolution of ubiquitination in immune signaling, and to inform the design of therapeutics that can modulate the cGAS-STING and ISG15 pathways in humans.